Bone In CKD Alkali Response Pilot Trial (BICARb Pilot Trial)

Abstract
Chronic kidney disease (CKD) is a state of impaired bone quality and strength. Renal
osteodystrophy (ROD), a global disorder of bone strength, is present in the vast majority of CKD
patients. Fracture rates are 2- to 14-fold greater in patients with than without CKD and increase
in parallel with CKD severity. CKD in children significantly impairs bone architecture and
strength at a time that is critical for developing healthy bones. Fracture rates are 2-3 times
higher in children with CKD than the general population. The attendant morbidity and mortality
associated with fractures in CKD has led to efforts to better understand their pathogenesis in
order to develop and study treatments that improve bone strength while simultaneously
providing an acceptable safety profile across the life-course. The lack of safe and proven anti-
fracture pharmacologic strategies in children and adults with CKD represents a fundamental
therapeutic gap in CKD management.
We propose a pilot, 6-month, randomized clinical trial in 15 children and 88 adults with CKD
stages 2 and 3 to test potassium citrate supplementation vs. placebo effects on bone strength
as measured by high resolution peripheral quantitative computed tomography (HR-pQCT). We
will also examine urinary net acid excretion and measures of bone turnover to understand how
potassium citrate effects skeletal health.
These aims will be achieved through the collaborative efforts of three institutions: Montefiore
Medical Center/ Children’s Hospital at Montefiore, Weill Cornell Medicine and Columbia
University Irving Medical Center. The research team has the necessary expertise and resources
to carry out this clinical trial. This study is innovative, as potassium citrate has never been tested
in a randomized, placebo-controlled trial in chronic kidney disease in children and adults. Bone
disease in pediatric kidney disease is understudied and this study will be an important first step
to evaluating potassium citrate as a therapeutic agent. This pilot study will provide important
information for design of a future larger U01 trial to evaluate effects of potassium citrate on bone
outcomes across the life-course.

Public health relevance
Project Narrative Chronic kidney disease is associated with bone loss and fractures in both children and adults, but bone protective therapies that are both proven and safe to use across the life-course in CKD are lacking. In this study, we will conduct a pilot, double-blinded, randomized, placebo-controlled trial in 15 children and 88 adults evaluating the skeletal effects of potassium alkali therapy. These data will form the basis for a larger U01 proposal to determine the efficacy of potassium citrate on mitigating the effects of CKD on bone.